Analysis of Chemical Structures and Therapeutic Activity of Agents for HIV, TB, and HBV (CHEMDB)

This contract will provide support for the ongoing survey of chemical and biological information for potential therapeutic compounds for HIV, tuberculosis (TB), hepatitis B virus (HBV). The resulting information and associated analytical tools are critical for the rational selection and discovery of potential therapies for HIV, TB, and HBV.